High-Intensity, dynamic-stability gait training in people with multiple sclerosis

Project Summary
The goal of this phase I/II multicenter clinical trial is to improve walking function, dynamic stability, and
community mobility in people with multiple sclerosis (MS) using a novel combination of high-intensity training
and an environment that challenges dynamic balance. There are two critical elements of this proposal: 1)
balance perturbations applied during treadmill walking will allow participants to develop neuromuscular
strategies to maintain upright posture, which will be refined and enhanced with repeated practice, and 2)
patients who engage in high-intensity training will improve their neuromuscular and cardiorespiratory capacity
to facilitate the ability to walk faster and further. Indeed, patients with mild or moderate MS present with altered
locomotor and postural control, and this 2X2 factorial design will delineate the individual and combined effects
of repeated exposure to postural perturbations during walking and high-intensity exercise that may enhance
locomotor and balance control in both laboratory conditions and in the real-world, where the locomotor and
postural demands are substantial. This study is predicated on the previous experience of the investigators with
high-intensity training in patients with other neurological disorders and promising results of a pilot study
demonstrating feasibility of dynamic balance treadmill training in people with MS. The present project will
attempt to delineate changes in clinical and laboratory measures of locomotor capacity following walking-
specific exercise training at high vs low intensity and with or without postural perturbations during treadmill
stepping (Aim 1). Aim 2 will demonstrate the relative efficacy of these strategies on dynamic postural control
(i.e., balance) and relate improvements in the response to perturbations to secondary measures of community
falls. Finally, Aim 3 will delineate changes in community mobility and participation following these various
exercise paradigms. We suggest that high-intensity locomotor training with postural perturbations will elicit the
largest changes in both locomotor and balance outcomes, and these combined gains will boost physical
activity in the community setting leading to improved quality of life.

Public health relevance
Project Narrative The proposed research will evaluate the individual and combined effects of high-intensity exercise and postural perturbations during treadmill training in people with multiple sclerosis. The effects of high-intensity treadmill training with postural perturbations on clinical and laboratory-based locomotor and balance outcomes, as well as changes in community mobility and participation will be demonstrated. This project meets a significant unmet need in the development of rehabilitation approaches in people with MS and has the potential for substantial public health impact.